Enhancing immune regulation in gene therapy for hemophilia

In recent years, 3 gene therapy protocols for the treatment of the bleeding disorders hemophilia A (coagulation
factor FVIII deficiency) and hemophilia B (FIX deficiency) have received regulatory approval, all using in vivo
adeno-associated viral (AAV) gene transfer into hepatocytes. We were the first to show that this approach
induces regulatory T cells (Treg) and promotes immune tolerance to the transgene product, a phenomenon that
has since been replicated in many different animal models. First evidence that this concept applies to humans
has now been obtained in a hemophilia A patient whose antibody against FVIII was eliminated by AAV gene
transfer. However, we found that the liver is also capable of priming CD8+ T cell responses against the transgene
product (through forming dendric cell (DC) - Kupffer cell (KC) - T cell networks). We uncovered critical innate
signals and mechanisms that lead to T cell activation, defined a role for levels of gene expression, and developed
adjunct immune modulation protocols that further improve immune regulation, reduce responses to viral capsid,
and enhance safety of therapy. Here, we will continue combining our team’s expertise in gene transfer,
immunology, and liver biology to define intrahepatic immune mechanisms and promote tolerance induction.
Additionally, we will incorporate new models of high translational relevance and study the effects caused by
hepatocyte steatosis. Ultimately, we aim for these studies to help eliminate the considerable inter-patient
variability in efficacy, toxicity/immune response, and durability of gene therapy. Approved drugs and clinical trials
utilize diverse capsids and very different vector doses. Realizing that efficacy in mice cannot be extrapolated to
humans, we developed models with primary human hepatocytes (PHHs) to better predict clinical performance
of candidate capsids. A major unknown is the impact of steatotic liver disease, which has become highly prevalent
in the population, including among hemophilia patients. Our preliminary data show increased transduction and
transgene expression in steatotic PHH. We hypothesize that steatosis significantly impacts transduction and
innate immune activation with capsid-dependent outcomes. We seek to 1. define the transduction patterns and
virus-host cell interactions of AAV vectors in normal vs steatotic (fatty) human liver using “humanized” mice, a
human liver 5-cell organoid model, and machine perfused human livers. 2. Define the mechanisms that link
innate immune responses and antigen trafficking to transgene product-specific immune responses in AAV
transduced liver. 3. Develop optimal immune regulation in gene therapy for hemophilia A by transient
administration of an immunocytokine. This proposal addresses specific aspects of hemophilia treatment as well
as questions of broader significance for liver-directed gene therapy. Moreover, addressing the complexity of the
liver’s immune system (incl. innate immune mechanisms, balance between adaptive immunity and tolerance,
impact of steatosis) is of considerable general significance.

Public health relevance
PROJECT NARRATIVE Gene therapy holds the promise of a lasting cure for the inherited bleeding disorder hemophilia but is troubled by immune responses. The goal of this project is overcome these immunological hurdles so that treatment by gene therapy is long-term in patients.